Individualized immunosuppression in organ transplant recipients based on real world evidence and artificial intelligence

PROJECT SUMMARY
Over 250,000 kidney transplant (KT) recipients depend on lifelong immunosuppressive therapy to prevent
rejection and graft failure. However, immunosuppression increases the risk of complications such as infections,
cancer, and cardiovascular disease (CVD), which together account for >70% of deaths in KT patients. To
optimize transplant outcomes while minimizing immunosuppression-associated adverse drug events (ADEs),
clinicians aim to choose the most appropriate immunosuppression regimen for the individual recipient's risk
profile. Nonetheless, this practice is often empirical and rudimentary because little clinical evidence guides it.
Our previous study found substantial disagreements between transplant centers' protocols, suggesting that
over- or under-immunosuppression could be prevalent.
Efforts to develop such evidence have been hampered by the limited granularity of current KT data. Existing
large-scale datasets primarily focus on transplant-specific outcomes like graft failure and death but fail to
capture broader clinical data, such as infections or blood glucose levels, which are essential for understanding
immunosuppression-associated ADEs. To address this gap, we plan to use Epic Cosmos, a nationwide
electronic health record database that launched in 2019 and now covers over 274 million individuals. Our
preliminary dataset includes 69,418 KT recipients (39% of the total) between 2014-2022, encompassing
detailed longitudinal data such as lab values, diagnoses, procedures, and prescriptions.
Additionally, traditional regression-based analyses are ill-equipped for evaluating individual treatment effects
(ITE) because they focus on average treatment effects, neglecting individual differences. To overcome this, we
propose using meta-learners, a class of machine learning algorithms designed to model ITE based on
individual characteristics. These algorithms can also identify the clinical factors that make specific treatments
more suitable for the individual recipient.
Leveraging the newly introduced database and the cutting-edge inferential method, we propose to create a
quantitative framework for immunosuppression individualization with the following aims: 1) to quantify the
individualized treatment effects of immunosuppression regimens on immunosuppression-related side effects,
2) to leverage the granular data from Cosmos to improve our proof-of-concept (PoC) meta-learners on
transplant outcomes, and 3) to develop a clinical decision support tool for immunosuppression tailoring.
This project will create the first framework to address the long-standing challenge of evidence-based
immunosuppression tailoring. This framework will be implemented to an open-access web application for
clinicals, potentially improving the survival and well-being of over 250,000 KT recipients. Our experience of
using meta-learners on large real-world datasets can potentially be leveraged to transform clinical decision-
making in diverse medical specialties.

Public health relevance
PROJECT NARRATIVE Over 250,000 kidney transplant patients depend on lifelong immunosuppression to prevent rejection and graft failure, but this treatment comes with significant adverse drug events, such as infections, cardiovascular diseases, and cancer, which account for >70% of deaths in this population. To address this issue, we will leverage an AI-based inferential method to characterize the individual treatment effects of various immunosuppression regimens according to the individual recipient's clinical profile, using the Epic Cosmos database, a new nationally-aggregated electronic health record database with high granularity and wide coverage (39% of all KT recipients, with planned expansions). This project aims to establish the first evidence-based framework for immunosuppression individualization, potentially improving the survival and well-being of over 250,000 kidney transplant patients and serving as a model for individualized clinical decision-making in other medical specialties.